Intraoperative imaging of breast cancer margins using Polarization Subtraction Te

DESCRIPTION (provided by applicant): LumaMed LLC proposes developing LumaScan, an innovative, cost effective and easy to use device for visualizing tumor margins during Breast Conservation Surgery (BCS), a method that is used in about 60-70% percent of breast cancer surgeries. Currently, breast tumors are approximately located using methods such as MRI or CT in a preoperative procedure. During surgery, however, there are no practical tools available that can accurately locate tumor margins or verify that the excised tissue lump has negative margins and the surgeon has to wait for histopathology results which can take several days. In 10 to 60% of BCS cases histopathology finds additional tumor at the margin. This situation results in repeat surgeries with the accompanied higher treatment cost, greater morbidity, infection risk, delayed adjuvant therapy, poor cosmetic outcomes and a patient's loss of confidence in the surgeon and wondering why didn't you get it all? LumaScan is based on Polarization Subtraction Imaging (PSI), a patented method that images the visible and near IR fluorescence and reflectance from superficial layers of the excised tissue in real time providing wide field, high resolution, and high contrast image guidance to the surgeon conducting a BCS surgical procedure in a practical, easy to use device. The wide field imaging allows a more comprehensive examination of the tissue surface, the high resolution approaches that of microscopic pathology and the high contrast permits the surgeon to assess tumor margins without the assistance of a pathologist. We aim to build clinical prototypes of LumaScan and test them in a clinical study of 40 subjects representing a wide range of breast cancer types. We further aim to show that the surgeon's ability to visualize cancer margins in the surgical suite using LumaScan is equal to that of a pathologist based on final histopathology images.

Public health relevance
PUBLIC HEALTH RELEVANCE: LumaMed's proposed product will improve outcomes and reduce costs in a variety of cancer surgeries, most notably lumpectomies for breast cancer removal. Present technologies fail to allow complete removal of breast cancer in up to 60% of lumpectomy surgeries necessitating costly follow on procedures. Once available, LumaMed should be able to save several thousand dollars per patient on average and reduce morbidity, reduce mortality and improve cosmesis for breast cancer patients electing lumpectomy.